Impact of germline mutations on the development of breast-implant associated anaplastic large cell lymphoma (BIA-ALCL) in women with textured breast implants

Breast implant-associated Anaplastic Large Cell Lymphoma (BIA-ALCL) is a subtype of T-cell lymphoma that
arises as a fluid collection or mass near textured breast implants. The lymphoma is usually confined to the fluid
surrounding the implants or to the capsule, a fibrous tissue around the implants, but in 10-20% of the cases, it
can spread to lymph nodes or present as an infiltrating mass. BIA-ALCL is treated successfully with implant
removal and capsulectomy in most patients, but ~20% require chemotherapy and/or radiotherapy.
Since the first description of BIA-ALCL in 1997, 733 total unique cases have been reported, with 36 patient
deaths, leading to warning communications from the FDA in 2011 and 2016, and ultimately, to the recall from
the market of textured implants produced by one of the most popular manufacturers in 2019. Global awareness
of this disease was thus increased, leading to improved identification and reporting of cases, as well as to an
urgent need for risk prediction for women with implants in place, currently estimated to be 10s of millions
worldwide. Although some women choose to remove the implants, the risk of getting BIA-ALCL from exposure
to textured implants is low and could be related to specific variables that remain largely unknown. Our
collaborative group through Memorial Sloan Kettering Cancer Center (MSKCC) has reported the incidence of
BIA-ALCL in a cohort of more than 3500 women with textured breast implants followed long term after surgery
for breast cancer (BC). In this cohort, the Cordeiro Cohort, unique in its nature, 11 patients developed BIA-
ALCL after an exposure of 7-10 years. This is the highest incidence described so far in the literature, however
no particular variable (related to the type of BC, exposure to chemo or radiation therapy, filling of the implants
with saline or silicone) was related to higher risk of lymphoma. Our collaborators from the Netherlands Cancer
Institute have recently reported preliminary data suggesting BRCA mutations might be more frequent in BIA-
ALCL cases than in the rest of the population. Within our cohort of 3500 women with implants followed long
term, many patients were tested for BRCA mutations and/or were included in the MSK-IMPACT study, a broad
tumor targeted sequencing effort that included the analysis of normal DNA to filter out germline mutations from
the tumor results. This unusual and absolutely unique combination of studies conducted on this population may
allow us to determine if BRCA and other germline mutations are related to lymphomagenesis in people with
breast implants, and the relative risk of women with germline mutations to develop BIA-ALCL. This in turn will
inform decision making for women with implants and their physicians on procedures such as textured implant
removal and reconstruction after mastectomy for women at higher risk of lymphoma. The identification of
germline mutations that might be related to lymphomagenesis will lead to future grant submissions and
evaluations of these mechanisms in other lymphoma subtypes, thus representing a milestone in our approach
to the disease.

Public health relevance
Project Narrative Currently, risk factors for breast-implant associated anaplastic large cell lymphoma (BIA–ALCL) among women with textured breast implants are not known, as well as the potential role of germline mutations, including BRCA, and other hereditary cancer susceptibility genes. Using our unique datasets, we will address this question in a cohort of women with textured implants followed long term where BIA–ALCL cases have been identified, and in a cohort where germline mutational status of cancer susceptibility genes is known. These results will help inform decision making for women with implants in place, as well as women considering breast reconstruction with implants after mastectomy for breast cancer.